ILLNESS AMONG PERSIAN GULF WAR VETERANS: CASE VALIDATION

The primary purpose of this project is to compare the true rate of confirmed disease among samples of veterans deployed to the Persian Gulf War with and without self-reported symptoms and illnesses, versus true rate of confirmed disease among samples of veterans not deployed, with and without these self-reported conditions.